TAS::75 0849::TAS HEALTH INFORMATION NATIONAL TRENDS SURVEY (HINTS) 4

This contract supports the Health Information National Trends Survey (HINTS) research initiative managed by the Health Communication and Informatics Research Program of the National Cancer Institute.